Developing multitarget enzyme inhibitors as safe and effective anti-migraine treatments

PROJECT SUMMARY/ABSTRACT
Migraine is the most common neurological disorder in the world characterized by episodes of severe headache
accompanied by a variety of symptoms such as nausea, vomiting, and depression of activity. Despite its
prevalence, treatments for migraine are poor. Nonspecific analgesics such as opioids and nonsteroidal anti-
inflammatory drugs (NSAIDs) produce pain relief, but repeated may produce addiction and gastric ulcers,
respectively. Traditional treatments for migraine such as triptans (serotonin receptor agonists) are plagued by
side effects, while repeated use of certain anti-migraine treatments worsen headache in a condition known as
medication-overuse headache (MOH). Thus, there is a desperate need for new non-opioid anti-migraine agents
with novel mechanisms of action. To this end, we aim to develop dual inhibitors, single small molecules that will
simultaneously inhibit two pain-related enzymes: soluble epoxide hydrolase (sEH) and fatty acid amide hydrolase
(FAAH). The most original and mechanistically distinct aspect of these compounds is their ability to inhibit two
different enzymes that play significant roles in pain and inflammation within the trigeminovascular system
simultaneously. Dual sEH/FAAH inhibitors described here have the potential to be used as a promising novel
non-opioid anti-migraine strategy. Our undergraduate students have identified several very potent dual inhibitors
and tested our lead inhibitor in vivo to demonstrate antinociception in a rat model of acute inflammatory pain.
We also observed that this dual inhibitor produces antinociception at lower doses than traditional NSAID
ketoprofen and does not produce behaviorally disruptive side effects. In the proposed studies we will rigorously
evaluate our two lead dual inhibitors in a rat model of migraine pain, synthesize and evaluate novel libraries of
ligands that are designed to interact simultaneously with both target enzymes, assess the anti-migraine effects
of these new ligands, and evaluate whether administration of our dual inhibitors produce opioid-like rewarding
effects or medication overuse headache. The compounds we propose to study represent a completely novel
non-opioid, groundbreaking effort in anti-migraine treatments. Because this class has different biological targets
from existing treatments, it represents an opportunity to solve long-standing problems that have been linked to
the existing anti-migraine therapies (e.g., opioids, triptans). To our knowledge, this proposal is the first attempt
to use the strategy of dual sEH/FAAH inhibitors as a rational anti-migraine therapeutic strategy. In addition, the
design principles, synthetic and in vivo strategies behind these dual inhibitors are truly multi-disciplinary,
rigorous, comprehensive, and innovative. Our studies will provide a firm foundation for the future investigation of
using this dual ligand strategy as a treatment for migraine pain. This proposal represents collaborative work
between two Hispanic-serving institutions, Cal State East Bay and Cal State Fullerton, with mentorship from the
Center for Clinical Pharmacology at Washington University School of Medicine in St. Louis. Our multidisciplinary
team has expertise and resources to tackle this project on the horizon to ensure continued success.

Public health relevance
PROJECT NARRATIVE Existing anti-migraine agents produce unpleasant side effects, worsen headache with repeated use, and innovation in the development of new anti-migraine treatments with novel mechanisms of action has been minimal. To solve this problem, we developed new dual inhibitors of soluble epoxide hydrolase (sEH) and fatty acid amide hydrolase (FAAH) to increase the levels of anti-inflammatory and analgesic metabolites in headache- relevant regions of the body, and, in this proposal, we will conduct rigorous structure-activity relationship studies, biological evaluation, chemical optimization, and behavioral testing of our dual inhibitors. Through in vitro and in vivo studies, our studies will reveal the utility of inhibiting two pain-related enzymes and provide the first steps towards the discovery and validation of novel sEH/FAAH-based anti-migraine treatments for human.